Intra-body Wireless Sensor Link - Large Animal Test

Abstract Summary
Intra-body Wireless Sensor Link – Large Animal Testing
This supplement will extend the work to develop new capabilities for the COSMIIC
System by testing the intra-body wireless system in a large animal model. Two modules under
current development are the “WING” and Sensor Withdrawn from A Remote Module
(SWARM). These will allow for real-time feedback of physiologic data to facilitate control for
closed-loop nerve stimulation algorithms. The WING module is intended to connect to wireless
devices and sensors outside the body, and the SWARM is designed for connection to tethered
sensors like inertial measurement units (IMUs) inside the body. Neither module, however,
supports data communication from untethered sensors within the body. With this supplement,
we propose to develop an intra-body wireless link that interfaces with the SWARM to enable
untethered, remote sensors to connect to the COSMIIC system. This will allow the COSMIIC
system to receive physiological feedback from sensors which cannot be safely accessed using
wires, or from sensors that only reside in the body for limited periods.
This supplement will further validate the intrabody wireless system acutely in vivo to
assess accuracy of data capture when measuring physiological data (bladder pressure) in real
time. Additionally, we will demonstrate triggered nerve stimulation from received data. This
final proof-of-concept experiment will demonstrate that the intrabody wireless system and the
COSMIIC system are feasible for closed-loop neuromodulation in future studies.

Public health relevance
Project Narrative Intra-body Wireless Sensor Link – Large Animal Test The aim of this supplement is to test a COSMIIC System module that can wirelessly connect with wireless sensors indwelling in the body, such as a bladder pressure sensor, in a large animal model.